Benzene exposure promotes neuroinflammation and metabolic dysregulation

ABSTRACT
Benzene is a prominent volatile organic compound (VOCs) that is present in water, food, paint,
detergents, vehicle exhaust, tobacco smoke, and e-cigarette vapors. Exposure to low doses of
environmental benzene in urban areas has been implicated in increasing the risk for metabolic
dysfunction across all ages. However, a direct link between exposure to low-dose benzene and
metabolic homeostasis is not yet established. Using the limited available literature on
environmental exposure to benzene and its metabolic outcomes, we performed a preliminary
meta-analysis and found a positive association between exposure to benzene and metabolic
impairments. Our preliminary studies provide strong evidence that chronic exposure to benzene
at varying low doses, modeling human exposure routes, induces significant insulin resistance
and hyperglycemia in rodents. Neuroinflammation is increasingly recognized as one of the causal
factors in the pathology of metabolic diseases. Glial cells (microglia and astrocytes) have recently
garnered specific attention for their role in neuroinflammatory responses in metabolic disorders.
Microglia, produce various pro-inflammatory molecules that are critical for the development of
peripheral metabolic imbalance and insulin resistance via hypothalamic inflammation. We show
that benzene exposure at several low doses relevant to occupational and environmental
exposure promotes robust hypothalamic glial activation and elevation in the hypothalamic
inflammatory IKKβ/NF-κB signaling pathway followed by the induction of endoplasmic reticulum
(ER) stress response. Our central hypothesis is that benzene-induced changes in microglial
function and IKKβ/NF-κB signaling underlie changes in whole-body glucose homeostasis and
metabolic responses. This hypothesis will be assessed with a novel murine model of air-pollution
combining molecular, genetic, and physiological approaches designed to manipulate both the
number and the inflammatory activation state of resident microglia in the following Specific
Aims: 1) To determine the contribution of exposure to low benzene concentrations to
neuroinflammation and metabolic regulation; 2) To determine the role of central IKKβ/NF-κB
inflammatory mechanism in a benzene-induced metabolic imbalance: 3) To determine the cellular
and molecular interplay between microglia neuroinflammation and ER stress response triggered
by benzene exposure. The proposed research will, for the first time, directly assess the role of
benzene-induced changes in glial function and inflammatory signaling in regulating whole-body
metabolism. Such a study will be of importance for shaping public health policy regarding
benzene exposure and its role in predisposition to develop metabolic diseases.

Public health relevance
NARRATIVE Type 2 diabetes (T2D) is among the most common and costly challenges confronting modern society. Benzene, one of the major components of air pollution has been found capable of inducing oxidative stress and inflammatory responses, which, may affect insulin resistance (IR), leading to whole-body metabolic imbalance and T2D. To understand the etiology of metabolic disorders, including obesity and T2D, it is essential that we gain insight into the mechanisms by which benzene can cause metabolic imbalance.